Basis of sex-specific therapeutic responses to obstructive sleep apnea: Oxidative stress, inflammation, and vascular function

Project Summary
The absolute number of cardiovascular-associated deaths in women exceed those in men. Key modifiable risk
factors for cardiovascular disease (CVD) rise as women age, when CVD prevalence becomes higher compared
with same-age men. The relatively abrupt, age-related reduction in estrogen — which had previously served as
a major antioxidant defense system—may be why. Compared with men (in whom greater early-life, ongoing
oxidative stress may serve as a compensatory adaptation as they age), women’s vascular systems may be more
vulnerable to this sharp rise in acute oxidative stress. One highly prevalent source of oxidative stress is
obstructive sleep apnea (OSA), which is associated with incident hypertension, CVD, and diabetes. OSA’s
intermittent hypoxemia and recurrent arousals cause deleterious health effects via oxidative stress, which
triggers inflammation-related decreases in nitric oxide bioavailability. Thus, oxidative stress is considered a key
intermediary through which OSA promotes vascular dysfunction. Even without OSA, middle-aged and older
women have worse vascular function than do age-matched men. Critically, OSA prevalence also rises sharply
as women age, suggesting sex-based pathophysiology. Our team’s preliminary data suggest sex-specific
differences in oxidative stress and vascular dysfunction in middle-aged and older women with OSA, as evidenced
by higher post-sleep nitrate levels and worse endothelial dysfunction compared with men; however, only women
have improved glycemic measures after three months of positive airway pressure (PAP) therapy. This may
indicate a sex-specific treatment effect on oxidative stress. Although it is the first line OSA treatment, a marked
number of OSA patients do not meet minimum PAP therapy adherence requirements. Thus, N-acetylcysteine, a
readily available, safe antioxidant may be a valuable, adjunct therapy for patients with OSA. To address these
significant issues, we will study women and men (aged 50–75 years) with moderate-to-severe OSA and minimal,
well-controlled comorbidities. Our primary objectives are to identify sex-specific differences in: a) the effects of
OSA on overnight oxidative stress and inflammatory biomarkers; b) vascular function; and c) effects of PAP
therapy plus N-acetylcysteine or placebo. Our overarching hypotheses are: 1) OSA differentially contributes to
adverse cardiovascular consequences in middle-aged and older women compared with age-matched men via
increased oxidative stress; 2) Women’s greater benefit from PAP therapy is due to their larger decline in
overnight oxidative stress; and 3) Adjunctive therapy with a novel supplement helps prevent CVD morbidity from
OSA. Given the staggering public health burden of CVD, targeting a treatable risk factor such as OSA in women
presents a critical opportunity to markedly improve health in an enormous, vulnerable population. Mitigating
OSA-induced oxidative stress with an accessible supplement—N-acetylcysteine—will be especially valuable for
those who struggle with PAP use or have only partial improvement in oxidative stress with PAP therapy.

Public health relevance
Project Narrative Morbidity and mortality from cardiovascular disease (CVD) rise as women age, likely due to reduced estrogen— which had previously served as their major antioxidant defense system. Consequently, the vascular systems of middle- and older-aged women may be poorly prepared for, and more vulnerable to, a sharp rise in acute oxidative stress, i.e., from obstructive sleep apnea (OSA), which contributes to the development of hypertension and CVD. To address these significant issues, we will study women and men aged 50-75 years with moderate- to-severe OSA to identify sex-specific differences in: a) the effects of OSA on overnight oxidative stress and inflammatory biomarkers; b) vascular function; and c) the effects of standard OSA therapy plus a supplemental antioxidant therapy or placebo.